Alzheimer's Disease Research Center

Overall: Summary/Abstract:
The University of Pittsburgh Alzheimer’s Disease Research Center (PITT-
ADRC) has shown a clear scientific evolution over the past three decades. Since our inception, we have
advanced the areas of AD neuropsychiatry, genetics, natural history of AD, validation of clinical criteria, and
clinico-pathological correlations, and have pioneered the development of PET amyloid tracers, which have
transformed AD research. We have used a multidisciplinary approach to better understand the transition from
normal cognition to dementia, have explored the biology of more aggressive forms of AD characterized by
psychosis, and have made and contributed to new insights in genetics. This solid scientific background and
investment in junior investigators has allowed the PITT-ADRC to develop areas of excellence, which form the
foundation of our Center going forward. These are reflected in the Center’s cores, and most notably in the
large number of studies we support in these areas in Pittsburgh and at national and international level.
The PITT-ADRC is committed to remain at the forefront of the scientific efforts to understand the
pathological processes involved in the etiology of AD. Along with the high level of research conducted by the
PITT-ADRC, we are also dedicated to developing strong training programs to promote the careers of young
investigators, consolidate the career of midlevel investigators, and to create strong ties with the community
through educational and support programs.
The PITT-ADRC is highly committed to leverage the strengths of the network of Centers to provide large
numbers of samples and standardized clinical data collection from our participants. The PITT-ADRC has
designed novel methodology that improves the accessibility of its database to local and national researchers,
and it has been a key player in multiple studies that advanced the understanding of AD pathology and its
possible implications for the development of novel treatments and other symptoms. Therefore, we provide an
excellent environment that enhances cutting-edge research by bringing together a multidisciplinary team of
investigators to study AD and other dementias, and to improve health care delivery.
The methodology proposed in this application will lead us to the creation of a unique and well-characterized
cohort of patients and normal control subjects assessed with state of the art clinical and biomarker methods.
This will allow us to test multiple scientific hypotheses and to examine the short- and long-term public health
outcomes of the pathophysiology of cognitive disorders in the adult.
We believe that the PITT -ADRC will be at the center of the new era of AD research that will require a
wealth of clinical and biological data, highly sophisticated biomarker methodologies, close inter-relationship
among centers and institutions, creation and optimization of human resources, and enhanced communication
with patients and families.

Public health relevance
Overall Narrative The principal goal of the University of Pittsburgh Alzheimer’s Disease Research Center (PITT-ADRC) is to perform and promote research that increases our understanding of the etiology and pathogenesis of Alzheimer’s disease (AD) and related dementias in order to ultimately advance new therapies. The PITT- ADRC provides the infrastructure to investigate the mechanisms underlying cognitive and behavioral symptoms, and to develop strategies for effective early diagnoses and treatments of AD. We will accomplish this goal with our own research, involving investigators at the University of Pittsburgh and nearby institutions in clinical and basic research, and with collaborations with other national and international centers of excellence, in an environment that supports innovative research and enhances training and educational opportunities for patients, caregivers, students, scientists and clinicians